Administrative Core

PROJECT SUMMARY ADMINISTRATIVE (ADMIN) CORE
In support of our mission to create a consortium to Generate, Characterize, and Validate Marmoset Models of
Alzheimer’s Disease (MARMO-AD), the Administrative Core (ADMIN) will oversee all administrative and
scientific functions of the MARMO-AD Consortium. The overarching goals of the ADMIN Core are to ensure
that MARMO-AD achieves its larger strategic goals as well as specific project aims and milestones. The ADMIN
Core oversees all administrative and integrated scientific functions across the research projects and cores, and
will execute its duties with guidance from the Consortium Steering Committee (CSC) and the Institutional
Advisory Committee (IAC). The ADMIN Core will operate under the leadership of the contact PD/PI Dr.
Silva at The University of Pittsburgh School of Medicine (PITT), with co-leadership from Consortium PD/PIs
Dr. Stacey Rizzo at PITT and Dr. Gregory Carter at The Jackson Laboratory (JAX); and involvement from
additional consortium investigators and managers. The ADMIN Core will provide leadership and oversight
in three key areas: 1) Scientific and technical strategy oversight and implementation; 2) Establishing and
monitoring milestones of the research projects and cores, including coordinating the activities and
interactions of the Project and Core Investigators to maximize resources; and 3) community engagement
and outreach including sharing of models, data, resources, and protocols. The Specific Aims of the ADMIN
Core are:
1. Deliver effective and efficient management, oversight, and evaluation of Consortium activities.
2. Facilitate interactions between and amongst cores to ensure timely and successful completion of
project and core aims and milestones.
3. Provide outreach and engagement with the broader research community.